HIRULOG COMPARED WITH HEPARIN IN ANGIOPLASTY

The purpose of the study is to determine whether hirulog is better than standard therapy with heparin in preventing blood clots during coronary angioplasty. Hirulog is a synthetic thrombin inhibitor that prevents blood clotting.